Vascular Imaging Biomarker Relationships to Alzheimer’s disease (VIBRA)

PROJECT SUMMARY / ABSTRACT
Improving vascular health is a potential strategy to delay the onset of Alzheimer's disease (AD) and related
dementias (ADRD). The overlap of cerebral small vessel disease (SVD) and AD pathology may be the most
common neuropathologic phenotype of age-related dementia. However, rarely do imaging studies of ADRD
include measures of SVD commonly observed on brain MRI scans in older adults. Due to challenges in
quantification in large cohort studies, manual reads are typically done; these are very time-consuming, prone to
human error, and lack spatial anatomic resolution. This distinction is most apparent in the Clinical Core studies
of NIH-funded Alzheimer's Disease Research Centers (ADRCs), where SVD biomarkers are technically
challenging, time-consuming, and often overlooked. Filling this critical gap will require technologies to robustly
identify SVD lesions on brain MRI. Recent technological advances make computerized SVD biomarkers
possible, reproducible, and feasible for large cohorts. Using various MRI pulse sequences, we have developed
novel deep-learning methods to accurately quantify SVD biomarkers, including cerebral microbleeds, white
matter hyperintensities, and enlarged perivascular spaces. These reading methods are reliable and offer greater
anatomic precision and dynamic range than previous scoring systems. Thus, our primary aim is to create an
inter-ADRC set of objectively measured SVD MRI biomarkers from large and diverse clinical cohorts to determine
the role of SVD in vascular contributions to ADRD. These ADRCs include 4,831 (49% minority) individuals at
risk for ADRD. We will use the rich clinical and neuroimaging (structural MRI) data within the South Texas, Wake
Forest, Wisconsin, and the University of California Davis ADRCs and their affiliated cohorts, including the
Vascular Contributions to Cognitive Impairment and Dementia consortium, the Multi-Ethnic Study of
Atherosclerosis, and The Wisconsin Registry for Alzheimer's Prevention to address unanswered questions
related to the contribution of SVD to ADRD. We will apply our deep learning models to address the following
Specific Aims: 1) Standardize quantification of cerebral SVD markers in diverse cohorts to allow objective
readings from neuroimaging data currently missing in the ADRCs. 2) Relate cerebral SVD lesions with clinical
cognitive staging, ADRD neuroimaging, and biofluid biomarkers in diverse ADRC cohorts. 3) Explore vascular
and metabolic pathways linking SVD to worse cognition and longitudinal cognitive decline in the context of ADRD
biomarkers. Further, we will share our robust machine learning models and implementation software with the
scientific community. This foundational work will produce and validate computerized methods for SVD
characterization and build a much-needed resource to assess vascular contributions to cognitive impairment in
AD/ADRD research in under-represented populations. Furthermore, this project will provide evidence for
reproducible and harmonized SVD outcomes critical to understanding the complexity of ADRD for adoption by
ADRC MRI research studies, which would be scalable with future grant-supported initiatives.
iii

Public health relevance
PROJECT NARRATIVE Vascular contributions to Alzheimer's disease and related dementias are recognized as important to understand and intervene in the complexity and disparities of dementia in older adults. Yet, most studies from Alzheimer's Disease Research Centers (ADRCs) do not measure cerebrovascular lesions because they require time- and labor-intensive methods. We propose to apply computerized novel "deep learning" methods to a consortium of studies from four ADRCs, and will explore the impact of cerebrovascular lesions on Alzheimer's disease biomarkers, cognitive impairment, and decline, establishing the value of new cerebrovascular measures for ADRC studies and yielding rich datasets for future analyses. iv